CCTN - FEMALE SITES

To obtain valid and reliable data to determine the contraceptive effectiveness, bleeding patterns, side effects and safety of novel LARC methods that can provide safe and effective contraception for women.